Administrative Core

PROJECT SUMMARY / ABSTRACT
ADMINISTRATIVE CORE
One of the advantages of the University of Michigan (UM) BACPAC MRC Administrative Core is that all of the
necessary leadership skills, faculty, staff, and procedures are already in place and have been for many years.
The leadership team proposing this MRC has a successful track record of working together with each other,
coordinating and successfully collaborating with large groups of inter-disciplinary investigators, conducting
multiple projects simultaneously, and successfully disseminating research findings. We are one of few pain
research groups that already has several ongoing NIH center grants and R01s that require us to perform deep
phenotyping studies before and after ongoing interventions - almost identical to those proposed in the
BACPAC MRC. One of our ongoing center grants (NIAMS CORT P50-AR070600) has an internal
organizational structure identical to the MRC BACPAC, in that a single large research project is supported by
several research cores as well as an Administrative Core. Our other center grant (NIDDK MAPP U01-
DK082345) has an external, network structure nearly identical to that proposed for BACPAC. We also have
many integrated ongoing NIH- or pharmaceutically funded studies using many of the proposed interventions in
our MRC, including exercise, Cognitive Behavioral Therapies, acupressure, and orally-administered
analgesics. We feel that this strong background of already working extensively in all of these areas, both with
our proposed team at UM as well as with other scientists around the world, helps strengthen our MRC
application in two ways: a) there is a greater likelihood we will be able to do what we propose in our MRC
because we are already doing it, and b) we bring many standardized research methods and procedures to the
BACPAC that might be considered for incorporation into broader BACPAC network efforts. To address the
needs of the larger UM BACPAC MRC the Administrative Core will address 4 specific aims. First, this core will
be responsible for the internal planning, organization, coordination, and overall administration of the UM
BACPAC MRC. Next, this core will help facilitate our UM MRC personnel playing key leadership and support
roles in our external interactions and contributions to the broader BACPAC initiative. Lastly, the core will
disseminate information regarding the MRC operations and findings to a broad constituency, from scientists to
clinicians to patients.